MECHANISM OF REACTIONS OF HEMOGLOBIN WITH LIGANDS

The oxygen carrying function of our blood depends on the structure of hemoglobin packed in red blood cells. Changes in the structure of hemoglobin often result in aberrations of the functional behavior and pathological conditions such as sickle cell anemia, hemolysis and cyanosis among others. This proposal is directed towards the key area of understanding the functional behavior or hemoglobin on a molecular basis. An attempt is being made to study the mechanism of cooperativity in the ligation reaction of isomers of the partially liganded species: Hb4L, Hb4L2, and Hb4L3. The geminate reaction of ligands with various hemoglobins will be studied to examine the effect of tertiary and quaternary structural changes on the geminate reaction and to relate it to the overall ligand reactivity. These studies will be made on M-hemoglobins, Hb Zurich, carp hemoglobin, opossum hemoglobin, human Hb A, and myglobins of elephant and aplysia. These hemoglobins have been selected for the study because they involve substitution at important positions in the heme pocket or they can switched to the two quaternary structures of hemoglobin simply by changing the pH of solution and/or adding inositolhexaphosphate. In addition to this, studies will also be made on some ferro and ferric model compounds using nitric oxide as the ligand. The techniques to be used, among others, are double mixing rapid kinetics and micro-second and nano-second flash-photolysis kinetics. The human hemoglobins chosen above are all of clinical interest.